Catheter for Complex Percutaneous Coronary Intervention

ABSTRACT
Nearly 1 million percutaneous coronary interventions (PCIs) are performed each year in the US. Approximately
70% of these cases are considered complex and require the treatment of calcified lesions, tortuous vessels,
and multi-vessel disease, often with total or sub-totally occluded lesions. Many operators avoid these more
complex cases, which are often not suitable for radial access approaches due to the limitations of smaller size
guide catheters and lack of support required to effectively deliver coronary stents and other interventional
devices. To overcome this limitation, guide extension catheters (GEC) have been developed to help deliver
stents in these challenging anatomies. GECs are currently utilized in approximately 18% of all coronary
interventions. However, GECs have several key shortcomings that have prevented their usage other than as a
bailout option. Specifically, current GECs are unable to access more distal tortuous lesions in 28% of cases,
resulting in the inability to deliver a stent in many cases. Blunt ended tubular GECs also have serious safety
issues with coronary artery dissection and/or plaque or thrombus embolization. Given that GECs are used in
~18% of all PCI cases, these data represent a significant volume of patients that are not treated effectively.
Hence, CrossLiner Inc. has developed a novel multi-functional GEC that combines the requirement for deeper
catheter intubation with a microcatheter leading tip, and pre-dilatation balloon on the leading element, to allow
safe crossing of severe lesions in tortuous coronary vessels, with balloon pre-dilatation, followed by crossing
the lesion with the guide extension and then seamless stent delivery. The combination of a GEC with a
seamless transition from the outer to the inner microcatheter-balloon provides the capability for easier stent
delivery, which can be unsheathed at the lesion as opposed to being delivered from a poorly supported
proximal location. This approach enabled by the CrossLiner GEC will substantially improve PCI in patients with
complex lesions while reducing risks, procedural duration, radiation/contrast exposure, stent dislodgement,
coronary dissection and perforation that exist with current GECs. Data from bench and in vivo Phase I studies
support the utility of CrossLiner’s multi-functional GEC by demonstrating a significant reduction in the force
required to pass a highly angulated segment while increasing the intubation depth compared to first-generation
devices. Results in vivo showed an increase in intubation depth from 5.6 cm to 12.9 cm and a 41% reduction in
the time to deliver a stent. Importantly, the CrossLiner GEC was able to successfully cross stented segments in
all vessels in a swine model of complex lesions, while first-generation devices were stuck proximal to the stent
or at the stent edge in ~75% of the coronary vessels tested. The CrossLiner system is now ready for final
process refinement and design control development (Aim 1) followed by usability evaluation, and regulatory
clearance (Aim 2). Successful execution of these Phase II studies will position the CrossLiner GEC system for
full commercialization of this highly innovative approach to improve the treatment for complex PCI patients.

Public health relevance
NARRATIVE Approximately 28% of guide extension catheters fail to achieve successful treatment in patients undergoing complex percutaneous coronary intervention due to inability to access, dilate and deliver stents to calcified lesions in tortuous vessels. The objective of this proposal is to assess the safety and usability of a novel multi- functional guide extension catheter system that is expected to improve the safe, effective and efficient revascularization of coronary lesions in the growing number of patients undergoing complex PCI.